Multidisciplinary undergraduate training program in Health-assistive Smart Environments

PROJECT SUMMARY/ABSTRACT
The world's population is aging. The resulting prevalence and ability to provide quality care for older
individuals with Alzheimer's disease and related dementias (ADRDs) and other chronic illnesses is a challenge
our society must address. Our vision is to address this challenge by providing a diverse body of undergraduate
students with the scientific, clinical, and research experience needed to understand health-assistive technology
and design technological solutions that aid with the challenges of aging and improve human health.
Undergraduates in neuroscience, psychology, sociology, computer science, and engineering (MSTEM)
programs as well as those in healthcare-related disciplines need a strong multi-disciplinary background to be
truly prepared for research in applying technology to gerontology issues. The objective of this renewal
application is to continue to enhance and lead a research training program for undergraduate students in the
fields of gerontology and technology-based assistive environments. This will be done through course work,
summer research programs, online materials and professional symposia to help other institutions develop
similar programs. The ultimate goal is to bring up a diverse generation of new graduate student researchers
and innovators who understand the need of continued work in the field for addressing the aging population
issues and begin their research careers prepared for gerontechnology oriented research. To accomplish our
goal, we will refine and offer a gerontechnology class that is geared toward multidisciplinary undergraduate
students (Aim 1). We will also refine and offer a gerontechnology-focused summer undergraduate research
experience (GSUR) program that will provide a team-based research opportunity for highly-qualified students
(Aim 2). To broaden the impact of the training program, we will offer mentoring support for senior capstone
projects and independent and clinical training projects related to gerontechnology (Aim 3). Finally, we will
broaden the impact of our program by disseminating training materials through online classes, Youtube videos,
and podcasts, and presenting methods and results of the training program at high-visibility gerontology and
technology meetings (Aim 4). In all of these efforts we will recruit and involve a diverse student body, including
women in STEM, minorities, persons with disabilities and individuals from disadvantaged backgrounds. The
proposed program is innovative because Gerontechnology-related undergraduate programs with a true multi-
disciplinary core are rare. The combination of serving both the local student body, summer students from
other programs, and individuals from outside the university through online materials, open seminars, and
workshops will bolster the quality, quantity, and diversity of highly prepared upcoming graduate researchers.
The project is significant because it will introduce many undergraduates to the issues faced by our society in
the coming decades, as well as prepare many of them to help develop new approaches to health care through
melding technology with traditional medical approaches.

Public health relevance
PROJECT NARRATIVE The proposed program represents a multi-faceted approach to multi-disciplinary undergraduate education, involvement of individuals from diverse groups in gerontechnology research, and preparation of individuals at many levels to meet the nation's need for gerontechnology research. The result of this project will be to educate groups of undergraduates in a multidisciplinary manner to prepare them for graduate school and research careers in the field. Additionally, the remote speakers, online materials, and symposia will bring in other researchers, teachers, and industry members to help spread knowledge about this field and its long-term impacts on our society. This program is relevant because it will expand and more greatly diversify the ranks of eldercare researchers in the fields of engineering, computer science, sociology, nursing, psychology, and others relevant to healthcare and MSTEM disciplines.